Development of Next-Generation Blood-to-barcode (B2B) chip for In Vivo CRISPR-Based Discovery of Metastasis Regulators

Project Summary:
Widespread dissemination together with emergence of tumor cell resistance to existing
therapeutic agents is ultimately responsible for almost 90% of cancer deaths. However,
the metastasis-promoting genetic programs and the underlying signaling networks
orchestrating the progression of the metastatic disease process remain poorly defined.
In order to develop effective anti-metastatic therapeutic agents and improve patient
outcomes, further progress elucidating the fundamental biology of metastasis is needed.
Notably, majority of the comparative genetic studies to date have relied on the primary
tumors and the metastatic lesions to facilitate the identification of genetics factors that
drive tumor progression and dissemination. However, deciphering drivers of metastasis
solely based on the genetic information from solid tumors is limiting due to genetic
divergence and tumor heterogeneity. Since metastatic tumor cells must leave the
primary tumor, circulating tumor cells (CTCs) that break free from primary tumors and
seed metastatic lesions are better suited to facilitate comprehensive understanding of
the metastatic disease process. However, efficient capture of CTCs and unbiased
genomic amplification are extremely challenging due to the rarity and fragility of CTCs.
Thus, new technologies and platforms are needed to effectively utilize the biology of
CTCs for systematic identification of metastasis-promoting genetic factors.
Recently we reported the very first genome-scale in vivo CTC CRISPR knockout screen
specifically designed to identify genetic-factors contributing to tumor cell dissemination.
Xenografted tumors were seeded with pooled CRISPR-edited metastatic prostate cancer
cells, each harboring single gene loss-of-function genetic alterations covering all protein
coding genes of the human genome. Using a high-performance microfluidic
immunomagnetic cell sorting approach for efficient CTC capture directly from mouse
blood coupled with next-generation sequencing (NGS) for barcoded guide RNA
enrichment analysis, we demonstrated the feasibility and reliability of the use of CTCs
for the identification of critical genetic factors promoting tumor cell dissemination thereby
illuminating targeted routes for inhibiting metastasis driving pathways.
In this project, we will develop a next-generation blood-to-barcode (B2B) chip (Aim1) that
accelerates in vivo CRISPR-based discovery efforts to identify critical genetic factors
impacting metastatic potential. The B2B chip will power a series of in vivo CRISPR
activation screens (Aim2) across a panel of human and mouse metastatic prostate
cancer cell lines strategically selected for modeling broad range of tumor metastatic
potential in vivo as well as origins of metastatic tumors. Collectively, these screens are
anticipated to reveal genetic factors that could be targeted therapeutically to limit the
development of metastatic tumors. Through systematic clinical relevancy prioritization
and validations using a battery of in vitro and in vivo approaches in prostate cancer
model systems (Aim3), clinical utility of our lead genetic factors as targeted anti-
metastatic agents will be established.

Public health relevance
Narrative: To make breakthroughs against lethal metastatic cancers, we need to identify the molecular mechanisms that allow cancer cells to escape existing line of treatments. In this project, we will develop an automated blood-to-barcode chip that accelerates CRISPR-based discovery efforts to identify druggable targets. Using systematic target validation and testing of drug-like molecules for establishing clinical utility, we provide a framework to expedite the development of new line of effective treatments against metastatic cancer.